Gardnerella promotion of N. gonorrhoeae pathogenesis

PROJECT SUMMARY
Neisseria gonorrhoeae is the causative agent of the sexually-transmitted infection gonorrhea and causes
serious complications in women, including pelvic inflammatory disease, ectopic pregnancy, and tubal-factor
infertility. Gonorrhea is more frequent in women who have bacterial vaginosis (BV). BV is the most common
gynecological disorder in women of childbearing age and is associated with adverse pregnancy outcomes and
enhanced transmission of sexually-transmitted diseases. We hypothesize that Gardnerella promotes N.
gonorrhoeae pathogenesis in ways that affect bacterial survival via immune evasion and ability to infect new
hosts via lipooligosaccharide (LOS) sialylation. Two Gardnerella virulence factors appear capable of shifting
the balance between two mechanisms that impact LOS-dependent infectivity traits of gonococci. First, the
cytolytic toxin vaginolysin releases epithelial cell contents in a CD59-dependent manner that promotes LOS
sialyation necessary for gonococcal immune evasion through the recruitment of factor H, a negative regulator
of complement killing. Second, a sialidase produced by some Gardnerella species can remove sialic acid from
gonococcal LOS, a step needed to promote transmission via binding to asialyloglycoprotein receptors on
endometrial cells and male urethral cells. These factors may act at different points in disease progression,
since vaginolysin is predicted to be produced by certain phase variants early in infection, and sialidase is made
by different phase variants at a later stage. Although Gardnerella spp. have not previously been genetically
tractable, we developed methods for making targeted, selectable mutations as well as complements in the
Gardnerella chromosome. We will use mutants of Gardnerella, N. gonorrhoeae, and human cell lines derived
from the cervix, uterus, and the male urethra to determine the mechanisms by which Gardnerella vaginolysin
and sialidase promote immune evasion and dissemination of N. gonorrhoeae.

Public health relevance
PROJECT NARRATIVE Neisseria gonorrhoeae infects the cervix, uterus, and Fallopian tubes in women, but these infections occur in the presence of other bacteria, especially the bacteria that cause bacterial vaginosis. Bacterial vaginosis is very common and increases the spread of other sexually transmitted infections including gonorrhea, chlamydia, herpes, and HIV. These studies will identify mechanisms by which bacterial vaginosis leads to increased N. gonorrhoeae survival and transmission.